Principal Project-Characterization of ANA+ and ANA-B cells in individuals with SLE and healthy subjects

Little is known about the differences between B cells reactive with nuclear antigen
(ANA+) and ANA- B cells in individuals with systemic lupus erythematosus (SLE) or
whether the regulation of ANA+ and ANA- B cells differs between SLE patients and
healthy individuals. We will study activation and transcriptional profile in ANA+ and
ANA- naïve, unswitched memory and switched memory B cells in individuals with active
SLE, individuals with SLE in remission and healthy individuals. We will determine the
antigenic and BCR repertoire of ANA+ B cells in these three cohorts to understand B
cell selection. These studies are designed to reveal if there are aspects of ANA+ B cells
in SLE that makes them susceptible to a therapeutic intervention that will not affect
those B cells engaged in a protective response.